Consortia for High-Throughput-Enabled Structural Biology Partnerships

While powerful for studying pathogenic secreted effectors, structural biology has not been used to a large extent to study effector-host protein interactions. In this proposal, we use known and novel secreted effectors and an experimental pipeline that will provide broad insights into how a model pathogen. Salmonella, subverts host cell funcfion. Aim 1 simultaneously provides key functional insights into effector protein potency and funcfion using broad set of assays, while at the same fime serves as an important selection step to focus structural characterization by the PSI network on the most valuable targets. Aim 2 provides valuable information about the host proteins and protein pathways, using cross-linking and proteomics, that each effector interacts with and provides the PSI network with a prioritized list of host protein targets for structural characterization. Aim 3 interrogates possible specific protein-protein interactions and provides a selection of validated protein-protein interactions and possibly ligands for structural characterizafion by PSI network. Ultimately, structure-funcfion studies of individual secreted effectors are invaluable to the host-pathogen research community. However, the insights into host-pathogen biology gained from this large parallel characterizafion effort with multiple effectors will advance understanding at a more complete systems level.

Public health relevance
Advanced mass spectrometry methods with structure determinations will allow for improved understanding of the interactions between human host proteins and pathogens; this research may lead to new therapies for infectious diseases. The specific pathogen model to be studied here is Salmonella, a pathogen that has been the cause of a number of significant food-bourne outbreaks in recent years.